Development of Microbiome-Sparing Antibacterials for Clostridioides difficile Infection

PROJECT SUMMARY/ABSTRACT
Hypervirulent, drug-resistant strains of Clostridioides difficile now greatly contribute to the overall morbidity
and mortality of C. difficile infection (CDI), resulting in relapse rates of up to 35%, nearly 30,000 deaths per
year, and a national burden over $4.5 billion annually. As such, there is an urgent need for the identification of
novel therapeutics for the treatment of recurrent CDI (rCDI). We have characterized the bacterial enzyme
FabK, enoyl-acyl carrier protein (ACP) reductase II, as an essential, druggable, and narrow-spectrum target
for CDI. FabK is a key enzyme in the bacterial fatty acid synthesis pathway (FAS II). Inhibition of enzymes in
this pathway has been shown to result in a strong antibacterial effect, as with the FabI (enoyl-ACP reductase
I) inhibitor isoniazid, and other FabI inhibitors currently in clinical trials. We have shown in mouse studies that
CdFabK inhibition is efficacious in CDI and results in low disruption to the normal flora of the lower bowel.
Further, our lead inhibitor series is compartmentalized to the gut with low oral absorption. Here, our objectives
are (i) to expand the SAR of our lead CdFabK inhibitor series while improving potency, (ii) to identify and
characterize novel chemotypes of CdFabK inhibitors, (iii) to demonstrate an in vivo narrow spectrum anti-
difficile effect with low disruption of microbiota. To achieve these objectives, we have organized a skilled team
with expertise in C. difficile microbiology, protein biochemistry, structural biology, synthetic chemistry, and in
vivo PK and efficacy to pursue the following specific aims: 1. Optimize PTIM and chemical related lead series
to improve antimicrobial potency. To accomplish this aim, we will employ structure-guided lead optimization
guided by enzymology, microbiology, and biophysical testing to advance 2nd generation compounds with
improved potency and new chemical features. 2. Identify novel inhibitor chemotypes and expand our
knowledge of inhibitor selectivity for CdFabK. This aim addresses the need to expand the chemical landscape
of FabK inhibitors to further understand the structural requirements for FabK inhibition and selectivity. To
accomplish this aim, we will employ a unique cell-based high-throughput screen, followed by hit validation,
lead characterization, and synthetic lead optimization. 3. Biological evaluation of lead compounds to obtain
efficacious drug candidates. In this aim, we will explore the pharmacological efficacy of CdFabK inhibitors
against rCDI, using in vitro antimicrobial, pharmacokinetic and animal model systems to prioritize best-in-class
molecules. We will also begin to define mechanistically the underlying protective effects of CdFabK inhibitors
in the microbiome environment. We expect these studies to yield fundamental insights regarding the inhibition
of the FAS-II pathway and CdFabK for treatment of CDI and will advance our understanding of the
microbiological effects of gut flora FAS-II inhibition. These results will further advance CdFabK inhibitors as a
new strategy for primary CDI treatment and prevention of recurrence.

Public health relevance
PROJECT NARRATIVE Recurrent Clostridioides difficile infection poses a serious threat to public health and contributes to nearly 30,000 deaths in the US per year. This research proposes to optimize and advance compounds with inhibitory activity against a key enzyme in the bacterial fatty acid synthesis pathway, enoyl-ACP reductase II (FabK), as novel therapeutics for selective treatment of Clostridioides difficile infection.